Novel approaches to target KEAP1 mutant tumors

PROJECT SUMMARY/ABSTRACT
Treating KRAS mutant lung adenocarcinoma (LUAD) remains a major challenge for clinical oncology.
Approximately 20% of KRAS mutant LUAD tumors carry loss-of-function mutations in KEAP1. Loss of KEAP1
hyper-activates NRF2 and dramatically accelerates KRAS-driven LUAD. Furthermore, LUAD patients with
KEAP1 mutations do not respond to standard-of-care, including the recently approved KrasG12C inhibitors,
making this one of the most aggressive and hard to treat solid tumors. Building on our prior studies, we have
observed that KEAP1 mutant cells have an altered metabolism that can be therapeutically targeted. In this
application we focus on characterizing the molecular mechanisms and therapeutic potential of targeting the
polyol and fructolysis pathways by both genetic and pharmacological approaches in multiple KRAS-driven
KEAP1 mutant LUAD pre-clinical models. In addition, using newly established models of KrasG12C-mutant
LUAD with KEAP1 mutations we will determine the therapeutic potential of standard of care KrasG12C inhibitor
Sotorasib in combination with a KHK inhibitor that blocks fructolysis. Ultimately, our studies will provide a
rationale for inhibiting the fructolysis in KEAP1 mutant LUAD and support the sub-stratification of patients with
hyperactivation of the NRF2 pathway as treatment responders to therapies targeting the polyol and fructolysis
pathways, which is pertinent to the goals of precision medicine.

Public health relevance
PROJECT NARRATIVE KRAS-driven non-small cell lung cancer (NSCLC) remains one of the most aggressive and lethal solid tumors. Therapeutic options and outcomes for NSCLC have remained virtually unchanged over the past thirty years. Using novel CRISPR/Cas9-based genome-engineering technologies we have established a unique and rapid research program to functionally characterize lung cancer mutations and identify genotype-specific metabolic vulnerabilities that can lead to novel therapeutic approaches in KRAS-driven lung cancer.